The mechanistic control of bone quality and joint crosstalk by osteocytes

PROJECT SUMMARY
Not applicable - no change from parent R01 grant.

Public health relevance
NARRATIVE The active role of osteocytes, cells embedded within bone, in maintaining skeletal health is disrupted with aging. Here we test the possibility that the disruption of osteocyte function with age contributes to age-related bone fragility and joint degeneration. Testing this hypothesis will advance our understanding of the cellular and molecular mechanisms controlling bone quality and joint disease, which will improve the success of clinical efforts to protect musculoskeletal health throughout the lifespan.